Integrative Approach to Comprehensive Analysis of High Throughput Data on a Cancer Center Level

Project Summary
Bioinformatics Facility, supported by the Cancer Center Support Grant (CCSG) awarded to the Wistar Institute,
collaborates with the vast majority of cancer center members on multiple research projects. My role as a Scientific
Director of the Bioinformatics Facility is to be engaged on all steps of many of those research programs. The
institute-wide involvement in cancer-related studies allows me to develop comprehensive data analyses
pipelines applicable across multiple programs, as well as to re-use result elements, including databases,
summarized and annotated datasets and other integrative resources, in analyses customized to particular
studies. In combination with project-specific research efforts, which in turn contribute to the existing
knowledgebase, the integrative approach provides a robust scientific environment for applying methods of
computational biology to various cancer-related studies as demonstrated in the application.

Public health relevance
Project Narrative The application is aimed to support cancer-related research efforts of The Wistar Institute investigators through computational expertise provided by Bioinformatics Shared Resource. Focus of the supported projects involve experiments designed to understand basic mechanisms of cancers, including melanoma, ovarian, prostate, various blood cancers, lung, colon and many others with the final goal of developing methods for cancer prevention, diagnosis and treatment.